Administrative Core

ABSTRACT – Administrative Core B, Ravetch
The Administrative Core will provide overall management of the administrative functions of the CCHI. This
includes proving clear and regular communication channels between the CCHI participants, the NIH, and the
External Scientific Advisory Group, reporting research findings annually and through publications, allocating
research resources between the projects and the core, and ensuring compliance on animal and human subjects
usage. The goals of the Administrative Core are 1) to provide scientific leadership and management for the
Center; 2) maintain regulatory and fiscal compliance and administrative oversight; and 3) coordinate
communications and research dissemination. The result of the execution of these goals will be a Center with
synergized research projects, streamlined and accurate reporting, and vast public dissemination. Deliverables
from the Administrative Core will include quarterly seminars and annual Distinguished Investigator lectures, a
CCHI-specific website with both public and private access, annual progress reports to the NIAID following NIH
policy and guidelines, multiple publications resulting from CCHI research, and data input to the ImmPort system.